Epigenetic Regulation of Head and Neck Cancer Immune Evasion

PROJECT SUMMARY
Head and Neck Squamous Cell Carcinomas (HNSCC) affect ~60,000 individuals in the US every year. Despite
aggressive treatment, the 5-year survival rate for HNSCC remains ~50% and frequently patients suffer relapse
and the development of metastatic lesions. Our previous work showed that NSD1, a histone methyltransferase
that specifically catalyzes di-methylation of histone H3 Lys36 (H3K36me2), is frequently inactivated in HNSCC.
Deletions, mutations and biochemical inhibition of NSD1 by the oncohistone H3K36M mutation are found in 15%
of HNSCC and define a novel disease subgroup with distinct molecular and clinical features. However, the
mechanism by which NSD1 inactivation promotes HNSCC development remains unclear. We recently reported
that NSD1 inactivation in HNSCC cell lines and patient samples resulted in profound DNA hypomethylation. Our
preliminary studies further demonstrated that NSD1 mutations in HNSCC are associated with increased genomic
instability and retrotransposon de-repression. Intriguingly, these molecular events are known to promote tumor
recognition by host immune system, yet NSD1 mutant tumors are unexpectedly immune “cold” with minimal
presence of tumor-infiltrating leukocytes and a reduced interferon response. Therefore, we propose to test the
hypothesis that NSD1 inactivation in HNSCC reduces tumor immunogenicity and facilitates immune evasion
through epigenetic silencing of the interferon signaling pathway. In Aim 1, we will define the role of NSD1 in
HNSCC immune evasion in vivo. We plan to employ syngeneic and genetically engineered mouse models of
HNSCC driven by NSD1 loss that have been developed in our lab. Together with the state-of-the-art single-cell
RNA-seq and multiplex imaging technologies, we will examine the changes in tumor microenvironment following
NSD1 loss. In Aim 2, we will study epigenetic mechanisms by which NSD1 regulates interferon response. We
propose to test the model that NSD1 antagonizes H3K27 tri-methylation (H3K27me3), a repressive histone mark
catalyzed by EZH2, to maintain STAT1 expression. In Aim 3, using syngeneic and humanized mouse models,
we will test if pharmacological inhibition of EZH2 can restore immune infiltration and delay the growth of NSD1-
deficient tumors alone or in combination with immune checkpoint inhibitor. Since only a minority of HNSCC
patients respond to immune checkpoint inhibitors, our expected results will have immediate translational
implication by nominating (1) NSD1/H3K36me2 as biomarkers for predicting therapeutic response to
immunotherapy and (2) an FDA-approved EZH2 inhibitor which can be combined with checkpoint inhibitors to
target poorly infiltrated, immune “cold” tumors. More broadly, this project will also contribute to our understanding
of chromatin-based mechanisms exploited by cancer cells to facilitate immune evasion.

Public health relevance
PROJECT NARRATIVE Head and neck squamous cell carcinoma (HNSCC) is a physically deforming and often fatal disease with limited treatment options. NSD1, a histone methyltransferase involved in epigenetic regulation of gene expression, is inactivated in ~15% of HNSCC. This project proposes to understand the mechanism by which NSD1 loss promotes the development of HNSCC, with a specific focus on the role of NSD1 in tumor immune escape.